Novel longevity enhancing pathways regulated by mTOR

Project Summary
We have recently identified a novel link between the mTOR pathway and a specific long noncoding RNA,
H19, which is critical during development and in adult stem cell populations. This work forms the basis for
an ongoing R01 project. In this supplement, the central hypothesis is that mTOR inhibition by Rapa
alleviates Alzheimer’s disease (AD) symptomatology by increasing the lncRNA H19.
We find that levels of H19 decrease during senescence and differentiation, however Rapa increases H19
levels, prevents senescence, and maintains pluripotency. The results suggest that increasing H19 levels in
response to mTOR inhibition may play a dual role, inhibiting senescence while simultaneously increasing
pluripotency in adult stem cell populations. H19 is expressed at low levels in the brain and increased
following some forms of damage, but little information exists regarding the function of H19 in the adult brain
or in the context of AD. We have evidence that this axis is active in human astrocytes and we will explore
the role of H19 in the CNS, first by evaluating the role of H19 during senescence of human astrocytes in
response to stressors relevant to AD, second by evaluating the expression of H19 in mouse models of AD
with and without rapamycin treatment, third by defining the specific binding partners of H19 in astrocytes
and neurons.

Public health relevance
Project Narrative This supplemental project will expand our analysis of a relatively new type of RNA species known as non- coding RNAs into Alzheimer’s disease. We have demonstrated that one non-coding RNA called H19 is linked to a longevity enhancing drug, rapamycin. We will explore the role of this non-coding RNA in models of Alzheimer’s disease with and without rapamycin treatment